Global HIV/AIDS Vaccine Enterprise

The Global HIV Vaccine Enterprise (the Enterprise) is a unique alliance of independent organizations around the world dedicated to accelerating the development of a preventive HIV vaccine. The Enterprise model represents a new global way of thinking about scientific problems and approaches to resolving them through the formulation of a shared Scientific Strategic Plan. All efforts of the Enterprise seek to accelerate the development of preventive HIV vaccine candidates through mutual coordination, collaboration, knowledge sharing, and recruitment of new resources and funders in the field. The Enterprise is a unique alliance of organizations that has the convening power to bring together an inclusive global alliance of top researchers, funders, advocacy groups, and stakeholders to catalyze fresh thinking, set new directions and advance global cooperation to develop an HIV vaccine.